PI3K Beta regulation of tumor metastasis

To improve treatments for breast cancer, it is critical to understand the mechanisms mediating metastasis.
Importantly, breast cancer metastasis is driven by paracrine and juxtacrine signaling between tumor and
stromal cells, such as macrophages and platelets. In the primary tumor, macrophages enhance tumor cell
invasion and intravasation, and in the lung, macrophages enhance tumor cell extravasation, survival and
growth. Platelets also play a major role in tumor metastasis, as platelets protect circulating tumor cells from
immune surveillance, induce tumor cell EMT, and recruit neutrophils to the metastatic site. Platelets also
enhance tumor cell adhesion and extravasation at distal sites.
This proposal examines the hypothesis that the Class I PI3K, PI3Kβ, is a key regulator of metastasis. Selective
inhibitors of PI3Kβ are available, but clinical trials have largely focused on the growth of PTEN-null tumors and
have not directly addressed metastasis. Our published data show that PI3Kβ in tumor cells is required for
invasion and experimental metastasis. New preliminary data in this grant show that macrophages and platelets
expressing mutant PI3Kβ are defective for stimulating a variety of pro-metastatic responses in tumor cells.
Importantly, we also show that pharmacological inhibition of PI3Kβ in mice causes a dramatic reduction in
tumor cell extravasation in vivo.
This project will directly test the role of PI3Kβ in metastasis. Aim 1 examines the role of PI3Kβ in juxtracrine
and paracrine signaling between tumor cells and macrophages, using in vitro co-culture experiments, in vivo
tumor studies, and intravital imaging. Aim 2 examines the role of PI3Kβ in platelet-tumor interactions, focusing
on platelet modulation of tumor cell signaling and stemness. Aim 3 will study the role of PI3Kβ during
spontaneous metastasis in vivo. We will express mutant PI3Kβ in tumor cells, globally in stromal cells, and
selectively in macrophages and platelets. These studies will use intravital imaging and a novel lung window
supported by Core A to define the behavior of tumor cells, macrophages and platelets during and after
extravasation. Together, these studies will advance our understanding of the role of PI3Kβ in tumor metastasis,
and provide important preclinical data supporting the use of PI3Kβ inhibitors for metastatic disease.

Public health relevance
Project Narrative Tumor metastasis is the major cause of mortality in human breast cancer, and understanding the biological mechanisms of metastasis is crucial for improving cancer treatment. The Class I PI 3-kinase, PI3Kβ, is a signaling protein and plays critical role in tumor cell invasion, and in the stromal cells that support tumor cell invasion. Existing clinical trials with PI3Kβ inhibitors have focused on the inhibition tumor growth. However, studies defining the mechanisms by which PI3Kβ mediates tumor invasion may refocus future trials on the treatment of patients with metastatic disease.